Fluorescence-based methods for microconnectivity analysis in neocortex

ABSTRACT
A comprehensive census of neural cell types in the brain, together with molecular-genetic
resources for cell-type specific labeling, is revolutionizing our ability to detect and monitor age,
disease, and experience-dependent changes in neural connectivity. Fluorescence-based
methods for quantitative synapse analysis would be easily adopted by the scientific community
and have been widely used in neuronal cultures, but have not been well-developed for analysis
of connectivity in brain networks, due to concerns about resolution and accuracy of detected
contacts and difficulty of reagent use. Here we will use recently-developed tools for fluorescent
synaptic labeling to develop a workflow to evaluate and mitigate concerns about fluorescence-
based measurements in brain tissue using state-of-the-art Expansion Microscopy methods. We
will then test the ability of these reagents to drive new insights about input-specific plasticity
during learning, using a well-characterized training paradigm where electrophysiological
changes in thalamocortical synaptic strength have been demonstrated.

Public health relevance
NARRATIVE We will use non-perturbing, genetically-encoded synaptic markers and state-of-the-art methods for Expansion Microscopy to evaluate the accuracy of fluorescence-based synapse detection in brain tissue. These tools will be used to drive new scientific insights about thalamocortical synaptic plasticity during learning. The close association of method validation and scientific inquiry proposed here will rigorously evaluate the potential of fluorescence-based analyses for neural circuit analysis that can be easily disseminated to the neuroscience community.